REGULATION OF SYNAPTIC CONNECTIONS DURING DEVELOPMENT

Two projects currently ongoing in my lab require the facilities of the GCRC. Both involve the analysis of the structure and function of neurotransmitter receptors.